Develop novel bispecific antibody-drug conjugates against metastatic lethal prostate cancer across subtype

Abstract
Antibody-drug conjugates (ADCs) have shown promise as targeted therapeutics for treating cancer, including
solid tumors. However, no ADC has gained FDA approval for treatment of prostate cancer. Multiple factors
including target selection and heterogeneity, as well as insufficient tumor uptake and intracellular delivery,
could have contributed to the limited success of current ADCs. To overcome these limitations and improve
treatment outcomes, we propose to develop novel bispecific ADCs (bisADCs) that target emerging tumor cell
surface antigens (CD46, B7-H3, and DLL3) with clinical validations. Bispecific targeting, which engages two
distinct tumor antigens simultaneously, holds promise for overcoming target heterogeneity, improving
internalization and tumor penetration. Unlike a combination of monoclonal ADCs, bisADCs possess the unique
ability to exploit synergistic interactions between targets and influence their intracellular fate. This concept
provides a compelling rationale for exploring bisADCs in prostate cancer treatment. We discovered CD46 as a
novel prostate cancer cell surface antigen that is persistently expressed across differentiation patterns. We
developed and translated a CD46-targeted ADC (FOR46) to phases I (NCT03575819) & II (NCT05011188)
trials. This CD46 ADC showed good tolerability and promising early efficacy signals in mCRPC patients. B7-
H3, another emerging target widely expressed in prostate cancer, has been targeted with ADCs like MGC018
and DS-7300, showing acceptable safety and encouraging efficacy in early-phase trials. B7-H3 negativity is
rare in adenocarcinomas but more common in CRPC with neuroendocrine features. DLL3 is overexpressed in
several neuroendocrine tumors, and a DLL3-targeted ADC (Rova-T) has been tested in neuroendocrine
prostate cancer in a phase I trial, making DLL3 a credentialed target for this subtype. We propose to develop
bisADCs based on those emerging novel targets to address both adenocarcinoma (B7-H3 x CD46) and small
cell neuroendocrine (DLL3 x CD46) prostate cancer. In Aim 1, we will determine target co-expression patterns
in mCRPC patient samples, generate novel human monoclonal antibodies and nanobodies against the targets
of interest, and construct bispecific antibodies (bisAbs) using robust Ig-like architectures, and generate
bisADCs carrying diverse drug payloads with clinical validation. In Aim 2, we will investigate the therapeutic
efficacy of B7-H3 x CD46 and DLL3 x CD46 bisADCs in animal models representing adenocarcinoma and
small cell neuroendocrine prostate cancer, respectively. We will benchmark the bisADCs against current ADCs
being tested in clinical trials, and identify lead bisADCs that demonstrate improved efficacy against
heterogeneous tumors, including target-low tumors, and enhanced survival in animal models of prostate
cancer. The proposed study presents a novel approach to next-generation ADC development and has a clear
path of translation to the clinic in prostate cancer patients who have progressed beyond current therapies.

Public health relevance
Narrative We aim to generate novel bispecific antibody-drug conjugates (bisADCs) against pairs of emerging prostate cancer cell surface antigens expressed by adenocarcinoma and small cell neuroendocrine cancer. BisADCs have unique advantages compared with a mix of monoclonal ADCs, as they trigger synergistic effects through antigen tethering that improve drug delivery and anti-tumor efficacy. By benchmarking against ADCs currently in clinical trials, we will identify lead bisADCs with superior therapeutic index against the two subtypes of prostate cancer, which will be translated to clinical testing in the near future.